Upgrading the CVID Biosensor Core Facility with a Biacore 8K instrument

Project Summary/Abstract As tremendous advances have occurred in genomic biology, gene sequencing technologies, and proteomic technologies, attention is increasingly focusing on gene products, most of which function by interacting with other gene products. A comprehensive understanding of physiological systems requires an in-depth definition of quantitative interactions between molecules. Biosensor technologies provides a powerful approach to define these interactions in label-free systems. Here we seek funds to upgrade the Biosensor Core facility in the Center of Vascular and Inflammatory Diseases (CVID) at the University of Maryland School of Medicine by the purchase of a Biacore 8K instrument. The major users of this Core have extensive expertise employing surface plasmon resonance technology with over 45 peer-reviewed publications employing the technology. The new instrument (Biacore 8K) will be integrated into the CVID Biosensor Core Facility and with the Center for Innovative Biomedical Resources (CIBR), the Administrative home for the University of Maryland School of Medicine Core facilities, thus providing the resource for our growing research community. The Biacore 8K will enhance the research of the Major users and Minor users by increasing the throughput capacity, by enhancing a more reproducible and optimized experimental design, and by increasing the sensitivity for measuring the interaction of low molecular weight molecules.

Public health relevance
Project Narrative The Center for Vascular and Inflammatory Disease at the University of Maryland School of Medicine is significantly enhancing its Biosensor Core by acquisition of a Biacore 8K instrument. This instrument will be used to explore new directions of research in Biomedical Sciences in the areas of Cardiovascular Biology, Cancer Biology, Lung Biology and Inflammation.